Mechanism-based combination therapy for cholangiocarcinoma

PROJECT SUMMARY/ABSTRACT
Cholangiocarcinoma (CCA) is an aggressive bile duct cancer. A majority of patients present with
advanced disease and die within a year. For these patients, chemotherapy is the main therapeutic option. Current
standards of care include gemcitabine-based regimens such as gemcitabine + cisplatin. However, the 5-year
survival rate has not been improved for several decades; tumors that respond initially become resistant, and
patients relapse. The literature documents that overexpression of DNA repair proteins contributes to resistance
to DNA damaging agents such as gemcitabine and cisplatin, current frontline agents for CCA. This proposal
seeks to identify gemcitabine-based combinations that overcome drug resistance and produce durable
remissions for patients with CCA.
To identify effective regimens and characterize molecular events that contribute to chemosensitivity or
resistance, we developed a panel of patient-derived xenograft (PDX) CCA models: CCA1-5 and gemcitabine-
resistant counterparts of CCA1 and CCA2 (CCA1.gemR and CCA2.gemR), with resistance acquired in vivo. We
propose to use these models to identify effective treatments for CCA. Our data support the hypothesis that
gemcitabine + a BET inhibitor (BETi) + a PARP inhibitor (PARPi) comprises effective treatment for this tumor
type. Bromodomain and extra-terminal domain (BET) proteins regulate the association of transcription
complexes to acetylated lysine residues of histones at specific chromosomal loci. BETi decrease expression of
genes whose expression is BET-dependent. Multiple BETi are in clinical trial.
Our data demonstrate: 1) that BETi + PARPi and also that BETi + gemcitabine are synergistic in vitro; 2)
the novel finding that gemR cells are more sensitive to BETi + PARPi than to gemcitabine + cisplatin; and 3) that
the BETi JQ1 + gemcitabine was more effective than gemcitabine as a single agent in the CCA1.gemR PDX in
vivo model (P<0.001). Further, our data suggest that sequential administration of BETi → gemcitabine will
produce BETi-mediated decreases in expression of DNA repair proteins and minimize gemcitabine resistance.
Proposed work evaluates the anti-tumor efficacy of the clinical BETi OTX015 + the PARPi olaparib +
gemcitabine, cisplatin, or gemcitabine + cisplatin in models of local and metastatic CCA. We will determine if
any of these regimens is superior to current standard of care, and perform whole genome sequencing of all
models to identify genetic and molecular characteristics associated with resistance. We will also generate
expression profiles of treated vs control tumors and of primary vs metastatic tumors. These data will provide a
basis for future work toward long-term goals of identifying gene products and pathways that contribute to drug
resistance or metastasis of CCA, and to develop effective treatment regimens using targeted agents.

Public health relevance
PROJECT NARRATIVE There are no effective treatments for patients with advanced cholangiocarcinoma (CCA); less than 10% of patients survive a year after diagnosis. Our data support the hypothesis that combining gemcitabine, a current standard of care for CCA, with a BETi + a PARPi comprises effective therapy for CCA even in tumor models that are insensitive to gemcitabine. Since mechanistic data in this application show that BETi decrease expression of DNA repair proteins that contribute to gemcitabine resistance and that PARPi augment this effect, we will determine the extent to which sequential administration of a BETi + PARPi decreases levels of DNA repair proteins and subsequent administration of gemcitabine produces durable tumor regressions.